Early-stage detection of hepatocellular carcinoma with hydralazine-augmented contrast ultrasound imaging

Abstract
Hepatocellular carcinoma (HCC) is the third leading cause of cancer-related deaths and a significant global health
concern. Early detection is crucial, as it significantly improves survival rates; patients diagnosed early can expect a
median survival of over 60 months, compared to less than 15 months for those diagnosed at advanced stages.
Unfortunately, most HCC cases are diagnosed late, underscoring the urgent need for developing better detection
methods. The current sensitivity of ultrasound for early-stage HCC detection is only about 45%, which increases to 63%
when alpha-fetoprotein (AFP) testing is added, indicating a pressing need for new imaging techniques to enhance
detection capabilities.
This research proposes a novel imaging method, hydralazine-augmented contrast ultrasound (HyCUS), which aims to
improve HCC visibility by increasing the image contrast between tumors and surrounding tissue by differentially
modulating their blood flow. The study will validate HyCUS using an autochthonous rat model of HCC with liver fibrosis,
assessing visibility through objective computational metrics and subjective assessments by radiologists.
The proposal has three specific aims. Specific Aim 1 will establish HyCUS as a technique for enhancing HCC visibility.
The underlying principle of the technique will be validated by measuring the differences in blood flow between HCC
and surrounding liver tissue after hydralazine administration. These differences will be correlated to Evans blue dye
uptake to assess visibility objectively. Specific Aim 2 will develop an imaging regimen for HyCUS. Understanding the
dose-response relationship of hydralazine is essential for clinical applications. These studies will investigate the effect
of different hydralazine doses on the visibility of lesions, the timing of contrast enhancement, and the duration of this
enhancement across various tumor sizes. Specific Aim 3 will evaluate the performance of HyCUS against existing
methods (B-mode ultrasound and contrast-enhanced ultrasound) in detecting early-stage HCC and measuring tumor
burden. These studies will track tumor formation and growth of HCC in a rat model, assessing the earliest detection
times and overall tumor burden through necropsy analysis post-imaging.
In conclusion, the proposed HyCUS technique represents a promising advancement in the early detection of HCC.
Enhancing the visibility of tumors through targeted blood flow modulation could significantly improve diagnostic
capabilities and ultimately improve patient outcomes in liver cancer management.

Public health relevance
Narrative Hepatocellular carcinoma (HCC) is a deadly liver cancer often detected too late. Early detection is crucial because it significantly improves survival rates and allows for more effective treatments. This study aims to improve early detection by developing a new ultrasound imaging method that enhances HCC visibility with the drug hydralazine used to treat hypertension.